Acinetobacter baumannii reservoirs within the host

PROJECT SUMMARY
Within hospitals, infected patients are sources of bacterial transmission, often through the colonization of high-
touch surfaces and equipment. Acinetobacter baumannii (Ab) is the Gram-negative bacterium with the highest
rate of multidrug resistance, and is a common cause of hospital-acquired pneumonia, bloodstream, soft tissue,
and urinary tract infections (UTIs). Although infected patients are sources of bacterial transmission within
hospitals, no common reservoirs in the human body have been established for Ab. Hospitals often institute active
surveillance strategies to mitigate the spread of bacteria between patients. However, outbreaks of Ab are still
common. Moreover, there are increasing reports of community-acquired Ab infections across the globe,
suggesting the existence of extra-hospital reservoirs. Two questions remain unanswered: how does the first
patient get infected, and how are new Ab strains introduced into hospitals? We have recently demonstrated that
Ab can hide undetected in murine bladder cells and then reactivate when stimulated by medical intervention.
This lead to the hypothesis that Ab can be asymptomatically carried and introduced into hospitals by patients in
intracellular reservoirs before hospitalization, and that subsequent medical interventions, such as the use of
catheters, could trigger a resurgence of Ab infection from such reservoirs. Here we will employ murine models
to explore this hypothesis. We recently developed catheter- and non-catheter-associated murine Ab UTI models
by employing UPAB1, a recent MDR community-acquired urinary clinical isolate. In the non-catheter-associated
UTI (ncUTI) model, although immunocompetent mice were not susceptible to long-term ncUTI,
immunocompromised mice exhibited high bacterial burdens in urine, bladders, and kidneys, taking up to 8 weeks
to completely resolve the infection. Notably, we found that introduction of a catheter into resolved mice led to the
development of Ab CAUTI in ~50% of the mice in just 24 hours. Genetic characterization of the recovered
bacteria confirmed that the same strain re-colonized the urinary tract. Moreover, intracellular bacteria were
detected in the bladders of resolved mice up to two months after resolution of the initial infection. We named
these small groups of intracellular bacteria ABIRs (Ab intracellular reservoirs). Furthermore, we also detected
intracellular bacteria in alveolar macrophages during a respiratory infection. More than 300,000 patients receive
mechanical ventilation in the US every year. Several complications often arise from the use of ventilators, such
as ventilator-associated pneumonia (VAP). We have developed a murine model for VAP. Here we propose to
investigate the relationship between ABIR formation and resurgent urinary and respiratory infections
Understanding how Ab strains reside in the host and the events causing resurgence may lead, in the future, to
modified surveillance strategies and/or preventative treatments to eradicate bacterial reservoirs previous to the
use of ventilators, catheters, and other treatments that weaken the host immune system.

Public health relevance
PROJECT NARRATIVE Acinetobacter baumannii (Ab) is a bacterium that is highly resistant to antibiotics and often causes outbreaks in hospitals. We propose that new Ab strains are introduced into hospitals by patients previously infected with this bacterium which can remain dormant in the patient, reemerging upon hospital treatments that weaken their immune systems. In this proposal we will employ mice models to investigate how and where Ab survives within the patients.